The Biology of Prostate Cancer Skeletal Metastases

OVERALL ABSTRACT
The common occurrence, marked debilitation and subsequent lethality of prostate cancer (PCa)
skeletal metastases has made it a major health concern. In the first fourteen years of this
program, we have addressed this important issue, resulting in a major impact on the field of
skeletal metastasis research, including promoting concepts such as crosstalk between tumor
and bone and the importance of therapeutically targeting the microenvironment, in addition to
tumor. This program has resulted in over 220-grant-related publications and set groundwork for
several clinical trials. In the current competitive renewal, we further attack this problem by
combining leading expertise in PCa research and bone biology. The central theme of this
Program is that there is crosstalk between PCa cells and the bone microenvironment that
fosters the development and progression of PCa metastasis. This crosstalk promotes the ability
of PCa cells to alter the bone microenvironment and render it fertile for tumor growth and
chemotherapeutic resistance. To expand on this theme the Program encompasses closely
interrelated hypotheses of four scientific projects supported by three cores. Project 1 explores
the novel finding that chemotherapy induces fusion of PCa cells to form multinuclear polyploid
giant cancer cells (PGCCs) that confer chemoresistance in the bone microenvironment; Project
2 examines the exciting idea that abscisic acid (ABA) induces PCa cells to adopt a phenotype
capable of existing in a dormant and chemoresistant state, with the capacity for long-term
survival and potential to develop into overt bone metastases; Project 3 explores the surprising
role that osteocytes (OCys) play in promoting PCa bone metastasis through activation of a
novel growth differentiation factor-15 (GDF15) receptor, GDFN family receptor alpha-like
precursor (GFRAL), that subsequently promotes PCa metastatic invasion and growth; Project 4
investigates the novel hypothesis that macrophage efferocytosis (engulfment) of apoptotic PCa
cells induces immunosuppressive signaling in the bone microenvironment that subsequently
enhances metastatic growth. These projects will be supported by three integral cores: Core A
(Administration) that will coordinate reporting, evaluation of progress, advisory board activities,
facilitate interactions among the projects and provide biostatistical support; Core B (Animal) will
provide mouse models and imaging and assistance with their use and Core C (Bone) will
provide expertise with bone histology processing, interpretation, and procurement of human
blood and bone marrow samples. This combination of investigators, projects and cores
provides a highly synergistic Program that is greater than the sum of its parts and will continue
to provide cutting-edge research and leadership in the field of PCa skeletal metastases.

Public health relevance
Over 90% of men with advanced prostate cancer (PCa) develop skeletal metastases which subsequently leads to their death. This Program is composed of a multidisciplinary team focused on understanding how the cancer spreads to and thrives in the skeleton so that we can develop methods to prevent or treat the spread of PCa to the bone.